Structure and Function of GABA-A receptors

Abstract
GABAA receptors are the major inhibitory neurotransmitter receptors in the brain and targets of
important therapeutics and drugs of abuse. Given their susceptibility to diverse therapeutic and abused
compounds and their involvement in anxiety disorders, excitotoxicity, and epilepsy, a comprehensive
understanding of this receptor is imperative. In this competing renewal application, we build upon our initial
elucidation of structures of the α1β2γ2 GABAA receptor subtype. Specific projects span structural
pharmacology, the mechanisms underlying ion channel gating, and studies of receptors in healthy and
diseased brain tissue. Our proposed efforts in structural pharmacology focus on unexplored drug classes
including allosteric modulators used in the clinic and prominently abused drugs. We propose to first identify
binding sites, then interrogate mechanisms of potentiation through a combination of functional assays and
computational approaches. Concurrently, we propose to address a significant gap in our understanding of
GABAA receptor signaling, the structure-based mechanism for channel gating. Employing time-resolved cryo-
EM techniques coupled with molecular dynamics, our aim is to capture the activated state, mapping transitions
among resting, activated, and desensitized states. To better understand the assemblies of GABAA receptors
found in their native environments, we propose to develop approaches for mapping subunit arrangements in
receptors in brain tissue. We propose to examine distinct brain regions to provide insights relevant to targeted
therapeutic interventions. This comprehensive, multidisciplinary approach integrates structural biology,
electrophysiology, and computational analyses, yielding an expanded understanding of GABAA receptors
relevant to basic signaling mechanisms, drug abuse, and drug development.

Public health relevance
Narrative This research application is focused on the structure and function of GABAA receptors, which are neurotransmitter receptors critical for regulating central nervous system function. They are major drug targets for treating anxiety, insomnia and convulsive disorders, and for induction and maintenance of anesthesia. The proposed studies will elucidate how therapeutics and drugs of abuse interact with this important class of cell surface receptors, how the receptors signal, and how they are assembled, providing essential information for improved therapeutics targeting these receptors.